The cadence of social communication: Unraveling speech rhythm and underlying neural, motor, and genetic mechanisms.

Project Summary/Abstract
Successful communication is dependent on a multitude of intricately coordinated skills that facilitate connections
between interlocutors, including prosody, or the rhythm, rate, and intonation of speech. Speech rhythm,
specifically, is critical for communicating intent and enhancing speech comprehension through predictable,
regularly-timed beats. Without rhythm, speech lacks the temporal guideposts that instruct the listener what to
listen for and when, leading to miscommunications (i.e., “let’s eat, mom!” vs. “let’s eat mom!”). Amongst autistic
individuals and their first-degree relatives, prosody, and speech rhythm specifically, has been identified as a
salient contributor to social communication differences. Parallel findings have been reported in fragile X
syndrome (FXS; the leading monogenetic cause of autism) and in FMR1 premutation (PM) carriers, who show
similar but less striking rhythmic variability. Together, these findings suggest a shared, heritable, neurobiological
mechanism underpinning speech and higher-order language skills impacted in autism, and linked to a known
autism risk gene. Importantly, recent acoustic research has revealed links between rhythmic variability, speech
rate, and FMR1-mediated molecular-genetic variation in females with FXS, who are largely understudied in FXS
research and tend to show less cognitive impairment than males. Notably, recent work in autism has pointed to
differences in cortical processing of continuous speech, whereas studies in FXS and the PM have identified
articulatory abnormalities, as potential perceptual and speech-motor mediators of speech-rhythm differences,
but their associations with speech rhythm remain largely unexplored. As such, evaluating the perception and
production of continuous speech in relation to speech rhythmicity in FMR1-mediated conditions is a critical next
step towards understanding the role of FMR1 in autism-related phenotypes. Further, exploring speech rhythm in
females with FXS and the PM will allow for greater characterization of the neural and speech-motor mechanisms
contributing to a broad spectrum of FMR1-mediated speech and language profiles, from clinically to sub-clinically
affected, without the confounding impact of intellectual impairment. Given mounting evidence of impacted cortical
speech processing and speech-motor differences in autism, as well as speech-motor incoordination in FMR1
conditions, we hypothesize that speech rhythmicity may be disrupted across in females with FXS and the PM
and contribute to pragmatic language differences. Moreover, we hypothesize that differences in speech rhythm
are differentially mediated by domain-general rhythmicity, speech-motor coordination, cortical speech
perception, and rooted in underlying variation in FMR1-mediated molecular-genetic correlates. If completed, the
proposed study has potential to provide key insights into the role of a known genetic mutation in the autism
language phenotype with relevance to future behavioral interventions.

Public health relevance
Project Narrative This project will examine speech rhythm, its underlying mechanisms, and its contributions to broader social communication profiles among females with fragile X syndrome and the FMR1 premutation. Specifically, we will examine general rhythmic, speech-motor, and perceptual contributors to speech rhythm differences in individuals with FMR1-mediated conditions to explore the complex relationship between FMR1-mediated variation and autism-related social communication abilities. Results of this study may help identify linguistic and physiological mechanisms contributing to speech, language, and social skills impacted in autism and FMR1 conditions, and linked to variation in the FMR1 gene.